Research Program: Cancer Epidemiology, Prevention & Control

PROJECT SUMMARY: CANCER EPIDEMIOLOGY, PREVENTION & CONTROL (CEPC)
The mission of the Cancer Epidemiology, Prevention & Control (CEPC) Program is to reduce the population
burden of cancer through the generation of knowledge of factors that contribute to cancer incidence, morbidity,
and mortality, and the development of effective, and as needed, tailored primary, secondary, and tertiary
cancer prevention strategies. To accomplish this mission, our faculty conduct clinical and community-based
studies in the general population, as well as in targeted and underserved populations. Program Leadership
includes Drs. Kathleen Malone and Marian Neuhouser as Co-Leaders and Drs. Margaret “Peggy” Hannon and
Scott Ramsey as Associate Program Leaders.
CEPC has 84 members from 21 departments across the Consortium, representing multiple scientific
disciplines including epidemiology, health services, health economics, health outcomes, behavioral sciences,
medical oncology, nutrition, psychology, and genetics. Thirty-six members have primary appointments at the
Fred Hutch, 47 have primary appointments at University of Washington, and 1 has a primary appointment at
Seattle Children's. Twenty-eight members joined CEPC in this grant period. In FY 2018, CEPC had $27.5M
(direct costs) in research funding, of which $17.4M (63.3%) is peer-reviewed, including $10.6M from NCI. In
addition, CEPC is the home of several large coordinating centers (not counted in research funding) which are
associated with an additional $9.3M in funding. CEPC program members published 1,871 papers in this grant
period of which 23% reflected intra-programmatic collaborations, 28% reflected inter-programmatic
collaborations, and 50% reflected external collaborations. Eleven of 12 Consortium Shared Resources were
utilized by CEPC members in the course of their work over the last cycle. This P30 grant assists this program
by providing administrative and logistical support for CEPC meetings, pilot funding for new research projects,
and recruitment resources for new faculty.
Key program resources include: the Cancer Surveillance System (CSS), our SEER Cancer Registry; the
Hutchinson Institute for Cancer Outcomes Research (HICOR); the UW Health Promotion Research Center
(HPRC); the Institute for Health Metrics and Evaluation (IHME); large well-characterized cohorts with extensive
data and biospecimens; national coordinating centers; and nationally-recognized cancer expertise that spans
the cancer control continuum. CEPC plays an important role in training the next generation of cancer
researchers. The CEPC research portfolio is focused on populations, problems, and inequities in our
catchment area and beyond.

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.